Comprehensive Training in Inter-Disciplinary Oral Health Research

Abstract
Making advances in oral health depends on training highly skilled scientists capable of conducting rigorous
dental, oral and craniofacial research, and on preparing them to work in multi- and interdisciplinary teams to
translate research findings into applications that improve the health of the public. The proposed training
program at the University of Washington (UW) is a competing renewal of an existing T90/R90 training grant
titled Comprehensive Training in Interdisciplinary Oral Health Research. By leveraging the breadth and
strength of academic research programs available at the UW, we have successfully created and refined a
comprehensive training program that offers a broad spectrum of interdisciplinary oral health research areas,
including public health, behavioral, and clinical, as well as basic and translational sciences. Our previous
NIDCR-funded training programs have been highly effective, with 85% of our former predoctoral and/or
postdoctoral trainees from the prior 15 years going on to work in research-intensive or research-related
positions. Research areas included are public health, behavioral, and clinical, as well as basic and translational
sciences. The Department of Oral Health Sciences (OHS) in the School of Dentistry serves as the focal point for
the program, providing core content for all trainees. Other participating departments include Biostatistics,
Epidemiology, and Health Systems & Population Health in the School of Public Health. Areas of focus are in
basic and translational sciences include molecular and genetic approaches to health and disease; craniofacial
structure, function and development; and stem cell biology/tissue regeneration/engineering. Our objectives are
to: 1) provide rigorous, discipline-based training in basic/translational or public health/behavioral/clinical oral
health research (achieved through departmental graduate programs and mentored research); and, 2) provide
experiences that develop trainees' skills for participating as strong contributing members of multi- and
interdisciplinary research teams (achieved through core seminars and research presentations, as well as
individualized career development opportunities, based on the trainee's Individual Development Plan). Pre-
doctoral training (2 PhD positions) is offered through PhD programs in all four participating departments. The
DDS/PhD program (3 positions) is offered through the Oral Health Sciences Graduate Program. Postdoctoral
training (4 positions) is available to candidates with an eligible doctoral degree to work on oral health research
topics, and this includes dentists seeking additional research training and experience. Included is 1 post-
doctoral position designated for a non-citizen dentist interested in advanced research training to prepare for a
research career, particularly in a US school of dentistry. The expected duration of appointments is 5 years for
pre-doctoral and 2 or 3 years for postdoctoral trainees. We evaluate the program based not only on process
measures (e.g., progress toward degree, near-term goals), but also on long-term outcomes, including positions
taken by trainees, their authorship on scientific publications, and record of grants as PI or key personnel.

Public health relevance
Project Narrative This grant supports the training of scientists working in a broad spectrum of oral health research fields that range from basic and translational biological research, to clinical, public health and sociobehavioral research. We provide trainees with strong research skills in their specific disciplines as well as with skills to work on multi- and interdisciplinary research teams to facilitate the translation of research findings into clinical and community-based applications that improve the public's health.